UNMASKING CRF ACTH CORTISOL AXIS IN HYPOTHALAMIC AMENORRHEA

Define mechanisms underlying neuroendocrine aberrations in women with functional hypothalamic amenorrhea, to test whether development of hypercortisolemia in amenorrhea is mediated by increased hypothalamic crf secondary to alpha-adrenergic activation and that inappropriate input of CRF may inhibit GnRH-LH pulsatility.